Impact of Disability and Social Determinants of Health on Patients and Hospitals in Value-Based Purchasing for Readmissions, Complications, and Bundled Care in Joint Replacement

The purpose of this study is to extend our prior work in understanding the risk structure of hospital readmissions and the impact of post-operative services for patients with joint replacement surgery on their physical functioning. We propose to take advantage of a unique patient-specific data sources (the Health and Retirement Study (HRS) and the National Health and Aging Trends Study (NHATS) both linked to Medicare claims data for patient-level measures of functional status, mobility limitations and social support to enhance current claims- data based risk models for both hospital readmissions and to understand the impact of different post-operative services on subsequent physical functioning. Using statewide Medicare claims data, we will also explore the use of census-derived variables that could serve as surrogate measures of the HRS and NHATS variables of functional status, mobility and social support that could be readily implemented as enhancements to nationwide claims data. Finally, we propose to study the impact of the “bundle” of services provided during the CMS defined post operative period and the effect those services have on patients' measured physical function. Our goal remains to protect vulnerable patients and the hospitals they frequent while providing the correct value signal to the health system.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Our study will determine the importance of accounting for individual patient characteristics such as functional status, mobility, and social support on patient outcomes after having hip and knee replacement surgery. We are interested in studying the influence of a patient's pre-operative functional status, mobility and social support on the patient's need for post-operative readmission, complications, and type of postoperative and rehabilitation services. This study is being performed to inform several new Medicare policies that compare, reward, or penalize hospital performance in providing hip and knee replacement services. We are conducting this study because of concern that not accounting for these types of individual patient characteristics in the new hospital payment policies puts patients with important limitations in functional status, mobility and social support at risk for unintended consequences, such as not receiving necessary rehabilitation after hip surgery.